Amphiregulin-Immunometabolism axis in oral immunity and inflammation during HIV infection

ABSTRACT
Systemic inﬂammation and mortality in people living with HIV (PLWH) are associated with mucosal
immune dysfunction and persistent viral reservoirs in the mucosa and lymphoid tissues. In the previous
project period, we have demonstrated the role of CD4+ FOXP3+regulatory T cells (Treg) dysregulation in
contributing to aging- and HIV-associated oral inﬂammation. The dysfunctional Tregs that we uncovered in the
oral mucosa of PLWH mimic tissue-resident CD4+ T cells expressing high levels of PD-1 and amphiregulin
(AREG). These cells correlate with CD38+HLADR+ CD4+T cell hyperactivation and dysfunction, toll-like
receptor 2 (TLR-2), and inﬂammasome/IL-1β signaling in vivo, and require IL-1β/AKT pathways for their
expansion in the context of HIV infection. Here we propose to address the role of oral fungal dysbiosis in
establishing the inﬂammatory environment and triggering oral immune cells to become dysfunctional. Building
on our more recent results from salivary metabolome analysis in PLWH, we will examine the underlying
pathways at the interface of dectin-1, AREG, inﬂammasome, and immunometabolism signaling pathways in
three well-connected aims. Thus, our proposal will reveal new directions to manage oral immune-dysfunction
and thereby systemic inﬂammation, and alter current clinical practice.

Public health relevance
NARRATIVE - PUBLIC RELEVANCE STATEMENT Systemic inﬂammation and mortality in people living with HIV (PLWH) are associated with mucosal immune dysfunction and persistent viral reservoirs in the mucosa and lymphoid tissues. Our proposal determines the underlying mechanism of immunological dysfunction in the mouth and will reveal new directions to address oral disease and systemic inﬂammation n PLWH.